Improving Patient Care Through Objective Monitoring of At-Home Repetitive Ritual Behaviors in Obsessive-Compulsive Disorder

Project Summary
Obsessive-compulsive disorder (OCD) is characterized by intrusive, distressing thoughts (obsessions) in
response to which an individual feels compelled to perform a repetitive behavior (compulsions), which are
performed in order to reduce the acute distress experienced by the patient but which perpetuate OCD
symptoms. Effective treatment requires accurate reporting of compulsive behaviors, and a key challenge is that
patients often underreport their behaviors to their providers because the short-term anxiety relief brought about
by engaging in the compulsion is preferable to the long-term challenge of resisting the compulsions in order to
treat the condition, thereby impairing the efficacy of these treatments. Available objective monitoring tools,
such as electrocardiogram (ECG) monitors, can detect periods of increased anxiety, while wrist-worn devices
can monitor behaviors such as hair pulling, but they have limited accuracy for detecting hand-washing
compulsions which are common in OCD and are thus not indicated for use in these patients. The overall goals
of this Phase 1 STTR are to address this key gap by developing and testing the feasibility of a technological
innovation involving a novel wearable smart-ring recording modality that is unintrusive and provides a more
objective measure of compulsive behavior to both patients and their therapists in order to appreciably improve
the effectiveness of OCD treatment. This ring device offers several innovations: It is a smart ring (1) that can
detect cleaning agents like water or alcohol (2) as well as repetitive behaviors (3) in order to objectively monitor
obsessive hand-washing or other ritualistic events (4). This information would be sent to a dashboard (5) with a
real-time log for a therapist to objectively measure the number of behaviors the ring detects and monitor wear-
time compliance (6). Specific aims of this proposal are to: 1) Optimize acceptability, feasibility and utility of the
ring device and its associated smartphone app/web interface through iterative 1:1 feedback from the range of
users of this technology (patients/providers); 2) Develop a prototype activity recording smart ring and
associated software system based on Aim 1 findings. The smart ring will be a miniature system that records
movement, temperature, and wetness. It will record while worn and wirelessly download data, pairing with a
smartphone app which will sync with a cloud storage modality; 3) Conduct a multi-phased acceptability,
feasibility and experimental assessment protocol first with healthy adults and then with patients with OCD,
followed by in-depth feedback interviews with clinicians. Advanced Medical Electronics has extensive
experience in biomedical development, and academic partners (Asnaani, Gooneratne) have expertise in OCD,
experimental methodology, mHealth, biomedical entrepreneurship, along with a prior track record of successful
collaboration on previous STTR funded studies and proposals. If successful, this project will provide patients
and health care providers with an unintrusive and more accurate tool for real-time monitoring of typical
compulsive behaviors in order to appreciably improve the efficacy of front-line treatments for OCD.

Public health relevance
Project Narrative The current application will develop a novel ring device designed to detect duration and frequency of engagement in behavioral compulsions (e.g., handwashing) with separate patient/healthcare data dashboards to assist patients with Obsessive Compulsive Disorder to more accurately monitor their compulsive behaviors to improve outcomes from behavior therapy. It includes repeated stakeholder feedback interviews, development of a device with key/most desirable features, and several experimental protocols to test for device acceptability, feasibility, and clinical utility by non-clinical and clinical samples.